Multidisciplinary AIDS Training Program

The goal of this training grant program is to prepare outstanding M.D, M.D-Ph.D. and Ph.D. trainees for careers
as scientific leaders in HIV/AIDS research. Despite enormous progress over nearly 4 decades towards reducing
the morbidity and mortality from HIV/AIDS, substantial challenges remain. These include developing a safe and
effective vaccine; development of a cure for HIV infection; improving the treatment and management of
opportunistic infections such as tuberculosis that burden HIV-infected patients in resource-limited settings;
managing the threat of antiretroviral drug resistance; developing safe and effective interventions to reduce HIV-
associated immune activation that leads to end-organ disease; and developing long-acting antiretroviral drugs
to facilitate life-long adherence to antiretroviral therapy. Progress on these fronts requires basic and translational
research to further our understanding of the molecular biology, pathogenesis, immunology, prevention and
therapeutics of HIV/AIDS. Over the past 30 years this program has trained 128 post-doctoral fellows, the majority
of whom have gone on to leadership positions in academia, industry and government. This program will provide
in-depth laboratory experience in a specific research area of HIV-related virology, immunology, epidemiology,
molecular genetics, molecular therapeutics, genomics and/or systems biology. Criteria for selecting trainees will
include prior training record, aptitude for research and demonstrated commitment to a research career. All
applicants will be selected by a Training Advisory Committee (TAC); 5 trainees will be selected annually.
Particular emphasis will be given to the recruitment of minorities and others underrepresented in AIDS research,
including women, individuals with disabilities and those from disadvantaged backgrounds. Basic elements of
the program include: 1) in-depth research training through laboratory investigation of a specific scientific question
in a particular area of AIDS research under mentorship of a senior investigator; 2) a didactic program consisting
of appropriately chosen courses specific to the trainee’s career goals; 3) frequent exposure to seminars,
workshops and colloquia related to AIDS; regular review of progress by individual Research Advisory
Committees and the TAC. The training facilities consist of state-of-the-art research laboratories at Harvard
Medical School, Harvard-TH Chan School of Public Health, Beth Israel-Deaconess Hospital, Brigham and
Women’s Hospital, Dana Farber Cancer Institute, Massachusetts General Hospital and the Ragon Institute of
MGH, Harvard and MIT. Independently funded senior and junior faculty at each of these institutions constitute
the faculty of this training program, representing diverse AIDS-related disciplines. The faculty collaborate
extensively with one another on AIDS research and will collaborate in directing this training program. The
Harvard Center for AIDS Research and the Harvard Medical School Clinical and Translational Science Center
(Harvard Catalyst) provide additional institutional resources that enrich the scientific experience and career
development of our trainees.

Public health relevance
HIV/AIDS remains a major threat to public health worldwide. Over the past three decades, Harvard faculty and their post-doctoral fellows supported by this training grant have made critical contributions to the progress in combating this epidemic that has come from research aimed at understanding the pathogenesis of HIV infection and its complications. The goal of this training program is to develop the next generation of scientific leaders poised to eliminate HIV/AIDS.